Helicase regulation during homologous recombination

Project Summary
Our chromosomes are continually bombarded with a variety of insults, resulting in damage that
must be repaired. By necessity, cells have evolved mechanisms to detect and repair broken
strands of DNA, thereby preventing loss of important genetic information. Double-stranded
DNA breaks (DSBs) are a type of damage that led to particularly disastrous outcomes. If not
corrected, DSBs can lead to gross chromosomal rearrangements, which are the hallmark of all
forms of cancer. Indeed, defects in HR-related proteins are associated with several severe genetic
diseases. Patients with these diseases often exhibit a strong predisposition for developing cancers
due to a loss of genome integrity. Surprisingly, DNA replication is the primary source of DSBs,
and as a consequence rapidly growing cells are especially dependent upon homologous DNA
recombination for survival. This dependence upon homologous recombination for the survival
of rapidly growing cells highlights the potential for using recombination inhibitors as highly
selective cancer therapies. To fully exploit the clinical potential of homologous recombination
inhibitors it will be essential that we more fully understand the detail molecular underpinnings
of recombination and the proteins that are involved in regulating and controlling this process.
To help better understand the molecular basis of homologous DNA recombination we have
developed powerful new experimental platforms that allow us to directly visualize hundreds of
individual DNA molecules at the single molecule level in real time. We are utilizing these unique
research tools to probe the fundamental basis for protein-nucleic acid interactions, with emphasis
placed upon understanding reactions relevant to human biology and disease. Here we will assess
how members of the RECQ family of ATP-dependent helicases function during long range
resection of double stranded DNA breaks. Our work will focus on the human RECQ helicases
BLM and WRN, both of which are associated with cancer and cancer predisposition syndromes.
We will define how the end resection machineries are assembled onto DNA ends, we will map
protein-protein and protein-DNA interactions that are required for end processing, we will
determine how end resection is coupled to downstream steps in homologous recombination, and
we will test disease relevant mutations to fully define their molecular defects. We will seek to
determine detailed molecular information related to these questions, and part of the significance
of this project lies in the depth of the answers we strive to obtain.

Public health relevance
Project Narrative Homologous recombination is a DNA repair pathway, which plays crucial roles in genetic disorders, cancer and aging. To help extend our understanding homologous recombination we have developed a powerful new experimental platform based on state-of-the-art optical microscopy that enables us to directly observe the proteins that participate in homologous recombination in real time. These powerful new research tools allow us to address questions in biomedical research that cannot be tackled with more traditional experimental approaches.